Imaging spatial transcriptome at single cell resolution to study eye regeneration in old age

ABSTRACT
To cure age-related diseases is of critical importance for the life quality of elderly people. One promising strategy
is to slow down aging or reverse aging with regenerative medicine. However, the regenerative capacity of stem
cells and their supportive microenvironments are drastically impaired in old age. Hence, to rejuvenate functions
of aged adult stem cells and their microenvironments or to maintain the youthful functions of adult stem cells in
old age are critical research directions to empower regenerative medicine to fight age-associated diseases. Here,
we propose to use a cutting-edge spatial transcriptomics method, Seq-Scope, to comprehensively examine the
aging, regeneration and rejuvenation of eye progenitor cells and their niche cells in the sexual planarians, a
champion of tissue regeneration. We aim to determine the molecular pathways that facilitate regeneration and
rejuvenation in old age. The proposed experiments will define datasets of fundamental importance in the
identification of niche cells and changes in aging and regeneration that will fuel long-term mechanistic studies.

Public health relevance
PROJECT NARRATIVE Regulations of stem cells and their microenvironments are altered in older age which lead to impaired damage repair and tissue regeneration in most animals examined. Here, we propose to use the cutting-edge spatial transcriptomic tools to identify changes in stem cells and their microenvironments in young and old planarians, and in the regeneration of new tissues in old planarians to facilitate our understanding of how an old planarian can regenerate a young eye. Such knowledge will help improve regenerative medicine in elderly patients.